Appalachian STAR Trial - Revision - Supplemental

Abstract
The proposed supplemental activities will reflect no change from original submission.

Public health relevance
Narrative The proposed supplemental activities will reflect no change from original submission.